Administrative Core

The Administrative Core is responsible for coordination of research activities, administration of resources, organization of research meetings and overseeing personnel placement, manuscript preparation and sub- mission, preparation of abstracts, reports, protocols for both animal (and ultimately human) research, and the supervision of budgets. This Core will work on a weekly basis with the Project Leaders, and facilitate science and technical support from the Cores, in order to accomplish the main objectives of the Program, maintain budgets and constructive interaction through meetings and electronic communications. The Administration will also prepare and ensure IRB and animal certifications are active, prepare annual reports, and motivate and support dissemination of Program research results. RELEVANCE (See instnictions): The Administrative Core will overview the day-to-day workings of the projects, the interaction between and co-ordination between the different projects in order to facilitate them in meeting their scientific goals. It aims facilitate communication, organize the meetings of the entire project, and provide administrative manage- ment.